Development of PRECISE: A Data Driven Personalized Suicide Prevention Intervention

Abstract
Individuals at high-risk of suicide vary substantially from one another. Over time, risk factors for suicide may
change within the same individual. Despite these differences, most treatments for suicidal thoughts assume that
the same intervention works equally well for all individuals at high-risk of suicide. Intensive longitudinal data
combined analyzed with network science, integrated with coaching, could be used to personalize suicide
prevention interventions to make them more effective and efficient. This K23 Career Development application
involves refining and testing a novel personalized treatment for individuals at high-risk called PeRsonalizEd
Clinical Intervention for Suicidal Events or PRECISE. PRECISE leverages idiographic statistical techniques
adopted from network science applied to ecological momentary assessment data to inform the tailoring of Safety
Planning and skills from Dialectical Behavior Therapy, two existing evidence-based treatments for suicide. In
Aim 1, a user-centered design approach will be used to refine PRECISE. Following the refinement of the
intervention, informed by data from a case series in Aim 1, we will then conduct a randomized controlled trial
comparing two different intensities of personalization. In the low-intensity arm, the 8-week treatment will be
tailored based on an initial two-week burst of ecological momentary assessment and one idiographic model. In
the high-intensity arm, participants complete eight weeks of ecological momentary assessment and idiographic
models are generated between each session. Coaches use the idiographic models to identify an individuals’
drivers of suicidal thoughts and conduct behavioral chain analyses to tailor specific skills to then teach, shape,
and reinforce in their individual clients. Assessments are completed pre-treatment, 8-weeks post-enrollment, and
32-weeks enrollment. We hypothesize that both arms will demonstrate clinically significant reductions in suicidal
ideation, but the high-intensity arm will be superior to the low-intensity arm in reducing ideation. Furthermore,
we anticipate that increases in effective emotion regulation skills and reductions in negative affect will account
for the decrease in suicidal ideation. As individuals learn more effective emotion regulation strategies, they will
experience less distress and thereby lower levels of suicidal ideation. This project is responsive to Objective 3.2
of the NIMH Strategic Plan and is integrated with a mentored research training plan focused on 1) suicide-specific
rigorous clinical trials, 2) user centered design in digital health, and 3) applications of network science to intensive
longitudinal data. The project and training goal will support the Candidate’s overarching goal to become a
clinician-scientist engaged in independent research on personalized, impactful, rapid acting suicide prevention
interventions for at risk adults.

Public health relevance
Project Narrative Suicide is a leading cause of death in the United States. Individuals at high-risk of suicide are a heterogeneous population. Building from an emerging line of evidence showing the effectiveness of personalized treatments for mental health problems, we plan to refine and test a personalized intervention for reducing suicidal thoughts and behaviors.